Role of interstitial cells of Cajal in patterned colonic motor activity

Summary
Colonic motility is the product of myogenic and neurogenic factors that regulate the excitability of smooth muscle
cells (SMCs). Part of the myogenic component of regulation is due to interstitial cells of Cajal (ICC) that have
critical functions in gastrointestinal (GI) motility. ICC form gap junctions with SMCs and convey regulatory inputs
to a syncytium of SMCs and PDGFRa+ cells (SIP syncytium). Some ICC generate pacemaker activity that is
responsible for phasic contractions in some regions of the GI tract. ICC are closely associated with motor
neurons, express receptors for major neurotransmitters and transduce inputs from enteric motor neuro-
transmission. The physiology of ICC is important because multiple studies have suggested that defects in ICC
develop in patients and may be responsible for a range of motility disorders. While much has been learned
about ICC in other organs of the GI tract, far less is known about ICC in the colon. During the past funding period
we characterized the basic behaviors of 3 of the 4 types of colonic ICC. Little is known about ICC in the myenteric
region (ICC-MY) that do not act as conventional pacemakers, yet we hypothesize they drive major propulsive
contractions in the colon. This hypothesis will be addressed by pursuing three specific aims: 1. Determine
mechanisms responsible for propagated Ca2+ waves in ICC-MY. 2. Determine the role of ICC in generating
patterned and propulsive contractions in the colon. 3. Characterize mechanisms of action of major
neurotransmitters on activation of ICC-MY. To pursue these aims we will use imaging, optogenetic,
transgenic, electrophysiological and contractile techniques that allow in depth testing of cellular mechanisms in
ICC without disruption of their anatomical and functional interactions with other cells in colonic muscles.
Integration of ICC behaviors with SMCs and PDGFRa+ cells will also be investigated to learn how subcellular
Ca2+ signaling in ICC can generate whole organ motility patterns. The impact of enteric motor neural inputs on
Ca2+ handling mechanisms in ICC-MY will also be investigated to understand previously overlooked mechanisms
of neural regulation of colonic motility. Parallel studies will be conducted on human colonic muscles to test the
role of signature ICC conductances and Ca2+ handling mechanisms in colonic motor activity. These comparative
studies will help develop a generalized concept of ICC functions in colonic motility and determine the validity of
using mice to help clarify the functions of ICC in human motility. This project will determine the role of ICC-MY
in patterned and propulsive contractions in the colon, and studies of animals with defects in ICC will demonstrate
how/why motility is negatively impacted by defects in or loss of ICC.

Public health relevance
Project Narrative Intrinsic and extrinsic nerves modulate movements of the GI tract, however the underlying patterning of GI motility depends upon intrinsic myogenic behaviors. The propulsive contractions of the colon (colonic migrating motor complexes or CMMC) are thought to be due to neurogenic motor patterns programmed within the myenteric plexus and direct innervation of smooth muscle cells. Recent work on this project has introduced important new information about how colonic motor activity is initiated and propagated. We are investigating mechanisms and functions of interstitial cells of Cajal (ICC) of which there are four classes in colonic muscles. These cells generate spontaneous, stochastic Ca2+ release events that activate Cl- channels (encoded by Ano1) in the plasma membrane, causing transmembrane inward currents. Neural inputs regulate Ca2+ signaling in ICC, thus modulating the myogenic drive on colonic motility. Loss or disabling of the basic functions of ICC (e.g. blocking Ca2+ signaling or ANO1 channels) causes defects in colonic motor activity, including decreased smooth muscle excitability, inhibition of phasic contractions, and disruption in major motility patterns, such as CMMCs. Because neural signals are transduced by ICC, damage to ICC makes it difficult or impossible to restore colonic motility by enhanced neural output. In the next funding period mechanisms responsible for Ca2+ transients in colonic ICC-MY and regulation of these events by enteric motor neurons will be characterized. Integration of activity between smooth muscle cells and ICC will be studied, and mechanisms responsible for initiation and propagation of propulsive contractions will be clarified. Animal models of ICC loss will also be characterized to develop new tools for testing therapeutics for motility disorders associated with ICC loss (e.g. slow transit constipation).